Frontiers in Emerging, Reemerging and Zoonotic Diseases and Diversity (FrERZD2)

We seek sponsorship to train the next generation of pandemic and emerging disease researchers in the FRONTIERS IN EMERGING, RE-EMERGING AND ZOONOTIC DISEASES. FrERZD will launch and sustain three vital undertakings: sophisticated courses for skills development; relevant vital research experiences; and career mentoring activities.
Responsive to PAR-20-289, it is designed for 16 trainees who are graduate and medical students, medical residents, postdoctoral fellows, and/or early-career faculty, and who also are US citizens or permanent residents. The week-long course will help to ensure that clinically active scientists (especially physicians) are able to obtain permission to participate. Too few laboratories are led by emerging, re-emerging and zoonotic disease scientists. We seek 5 years of sponsorship to offer FrERZD courses at Morehouse School of Medicine (MSM) in 2021, 2023, and 2025 and Ponce Health Sciences University (PHSU in 2022 and 2024. Under the overall directorship of Gerald Schatten from Pittsburgh, along with Jonathan Stiles at MSM, Idhaliz Flores from PHSU, and Calvin Simerly, also from Pittsburgh, FrERZD is overseen by an external scientific advisory committee. It offers dynamic advanced training courses consisting of daily lectures on emerging concepts, followed by extended discussion, laboratory research, technologically intense workshops, and informal seminars. Six specific aims are proposed. Aim 1. Provide conceptual education and experimental training.
Aim 2. Provide background information and self-reflective exercises and demonstrations to understand, appreciate, and address emerging, reemerging and zoonotic diseases and their influence on health care. Aim 3. Sponsor meaningful mentored research. Aim 4. Discuss career planning. Aim 5. Educate participants on the responsible conduct of research. Aim 6. Provide unbiased, quantitative, independent mechanisms to track trainees’ careers, comprehensively and longitudinally. The program’s name, FRONTIERS IN EMERGING, RE-EMERGING AND ZOONOTIC DISEASES, acknowledges while some health threats subside, our realization that new emerging, reemerging, and zoonotic diseases will arise that must be timely addressed. Overall, in conducting this program, we will continue to enhance and expand the research careers of the most promising scientists for the NIAID workforce.

Public health relevance
We seek sponsorship for this initiative - entitled FRONTIERS IN EMERGING, REEMERGING AND ZOONOTIC DISEASES (FrERZD) - to train a new generation of pandemic and emerging disease researchers by providing urgent and essential knowledge and the abilities necessary to manage pandemic responses. This training course, offered at Morehouse School of Medicine and Ponce Health Sciences University, will launch and sustain three vital undertakings: sophisticated courses for skills development, addressing the causes, prevention and healing strategies for dealing with pandemics at the national level; relevant vital research experiences addressing these national threats; and career-mentoring activities to promote the careers of specialists in relevant biomedical professions. FrERZD, responsive to PAR-20-289 (NIAID Research Education R25 Program), is designed for graduate and medical students, medical residents, postdoctoral fellows, and/or early career faculty and to enhance and expand the research careers of the most promising scientists in the NIAID workforce.